Discovery of Molecular Probes and Therapeutic Leads, Equip Supp

ABSTRACT
The goal of this supplement to R01 GM132460 will be to support the toolkit being developed under
the parent award through acquisition of a preparative HPLC instrument. The goal of the parent
R01 is to improve the practicality, generality, tunability and scope of tetrazine ligation. We will
develop a new generation of catalysts and reagents for tetrazine cross coupling and will apply
these tools to chemical glycobiology applications. We will continue to develop novel tetrazines
that can serve a dual role in enabling protein purification followed by subsequent site-selective
bioorthogonal chemistry, and we propose to develop efficient catalytic methods for ‘turning on’
rapid bioorthogonal chemistry in biological context. Mechanistic inquiry will continue to guide our
discovery efforts as will continued industrial collaboration with the chemical biology group at
Pfizer. Efforts to commercialize the tool molecules will be continued.
The success of this proposal is critically dependent on small molecule purification which is greatly
facilitated by preparative high performance liquid chromatography (prep-HPLC). Currently, the
Fox group does not have access to a prep-HPLC instrument. The proposed instrument will greatly
accelerate research and maximize the impact of this R01-funded program. All aims of this grant
will derive tremendous benefit from the proposed prep-HPLC.

Public health relevance
Project Narrative The goal of this adminstrative supplement will be to support the purchase of a preparative HPLC instrument to support the research on the parent R01. The goal of the parent award is developing a diverse set of new chemical tools centered on tetrazine ligation– the fastest known bioorthogonal reaction. The work will advance new biotechnological, biomedical and pharmaceutical applications through new chemical tools for labeling biomolecules in the intracellular environment, new methods for selectively tagging and assembling proteins, and new technology for probing biological targets in living systems with spatiotemporal control.